Using genomics and extensive phenotyping to dissect the relationships between substance use disorders and chronic pain

Project Abstract
Chronic pain is one of the most pressing public health burdens in the United States, affecting up to 20% of the
population. Substance use disorders (SUDs) often co-occur with chronic pain. The relationship between
chronic pain and opioid use disorder is often attributed to over-use in connection with post-operative pain, but
the underlying mechanisms for chronic pain’s comorbidity with other SUDs (alcohol, tobacco, cannabis) are
unknown. Depression often co-occurs with both chronic pain and SUDs and could be a mediator of the
relationship between pain and SUDs. Socioenvironmental factors, including experiencing discrimination, may
also play a role. Given the role of the brain’s reward system in both pain and SUDs, it is also plausible that
some of the same genetic risk variants contribute to both chronic pain and SUDs. Both chronic pain and SUDs
are moderately heritable and genome-wide association studies have identified loci contributing to their liability.
However, these studies have focused on common variants in predominantly European ancestry individuals.
This proposal, in response to RFA-PM-23-002, would leverage the multi-ancestral phenotypic and genomic
data in All of Us to characterize the relationships between four of the most common SUDs (alcohol, tobacco,
cannabis, and opioid use disorders) and chronic pain in a diverse sample. Our first aim will be to curate
electronic health records to define a broad measure of chronic pain, as well as more detailed subtypes (e.g.,
neuropathic vs. nociceptive pain, musculoskeletal vs. visceral pain), and examine how these are related to
SUDs. We will test whether a common risk factor, depression, partially mediates the relationship between
chronic pain and SUDs. Further, we will estimate the extent to which social determinants of health (e.g.,
gender, socioeconomic background, experiencing discrimination) are associated with both chronic pain and
SUDs. Our second aim will involve whole-genome analyses of chronic pain in multiple ancestries, identifying
the genes and pathways that contribute to both chronic pain and SUDs, and employing genetically-informed
causal inference models to identify reciprocal relationships. We will use the whole genome sequence data in
All of Us to identify genomic factors – common genetic variants, as well as rare variants – that contribute to risk
for chronic pain. Next, we will use genomic structural equation modeling and gene network analyses to identify
genes and biological pathways that are shared (or distinct) between chronic pain and SUDs. Finally, we will
apply multiple causal inference approaches to assess whether there is evidence for causal relationships
between chronic pain and SUDs. This proposal will clarify the socioenvironmental and genetic mechanisms
associated with chronic pain and SUDs through detailed phenotypic and large-scale genomic analyses on a
diverse sample. The findings from these analyses will advance our understanding of why SUDs and chronic
pain co-occur, leading to improved treatment and prevention efforts through the identification of shared
biological pathways and modifiable psychosocial factors.

Public health relevance
Project Narrative Substance use disorders and chronic pain frequently co-occur, yet the mechanisms driving their comorbidity are poorly understood. This application proposes to leverage whole genome sequence data and electronic health records data on chronic pain (including its subtypes) and substance use disorders (alcohol, tobacco, cannabis, and opioids) to better understand their relationship across multiple domains (phenotypic, genomic, biological overlap) and all represented ancestry groups in the All of Us program. The findings from this proposal will inform our understanding of the relationships between SUDs and chronic pain and eventually lead to improved treatment and prevention efforts.